The Role of Nuclear Transport Dynamics in Metformin's Geroprotective Effects

Abstract
As the cell ages, the nuclear pore deteriorates, leading to dysregulated nucleocytoplasmic transport. Emerging
evidence indicates that this deterioration is pathogenic in aging-related decline. Thus, targeting the nuclear pore
complex (NPC), the 30+ protein, megadalton, heteromultimeric sole gateway between the nucleus and the
cytoplasm, may be of therapeutic value in promoting healthy aging. We have previously shown that NPC
deterioration can be halted or even reversed by metformin, a member of the biguanide class of drugs commonly
prescribed in type 2 diabetes. Our previous work identified a conserved pathway that connects metformin action
to the regulation of nucleocytoplasmic transport and modulation of growth and aging in the nematode, C. elegans.
The central feature of this pathway is that normal mitochondrial function facilitates specific aspects of transport
through the NPC. As organisms age, mitochondria facilitate nuclear leakiness, allowing cargoes to exit and enter
the nucleus inappropriately, contributing to aging-related declines in cellular function. Alternatively, when cells
are exposed to metformin, a modulator of mitochondrial complex I energetics, passive nuclear transport is
inhibited leading to halted cell growth and increased lifespan. To fully understand how metformin exacts its
effects on the cell in aging, it is important to determine its impact on nucleocytoplasmic trafficking. My hypothesis
is that biguanides promote longevity by altering passive and/or facilitated transport of specific cargoes through
the NPC. I will elucidate the functional mechanisms by which changes in nucleocytoplasmic transport dynamics
govern aging and longevity in response to metformin. The goal of my project is twofold 1) to comprehensively
define mechanisms of altered nuclear transport with metformin, and 2) to identify and functionally characterize
nuclear transport cargoes that are aberrantly localized in aging and restored by metformin. As an inextricably
linked consequence of conducting this work, I will obtain critical training in state-of-the-art methodologies in aging
research, enabling me to do future high impact work on the fundamental biology of aging. My plan for training
and mentorship at leading institutions and laboratories in aging research positions me well to achieve these
goals. Ultimately, identification of aberrantly localized NPC cargoes in aging, and characterization of their role in
aging and metformin-mediated lifespan extension is expected to illuminate new therapeutic targets in aging and
aging-related disease.

Public health relevance
Project Narrative Aging has now been formally recognized as a disease by the World Health Organization, so the interest to develop therapies either by novel or repurposing drugs to combat aging and its consequences will continue to increase. The goals of my project are to understand the ability of metformin, the world’s most commonly used drug for type 2 diabetes, to promote healthy aging, and to gain essential training in aging research to jump-start the next phase of my training. I will do this by studying how messages travel around the cells of our body, how this process goes wrong in aging, and how metformin is positioned to correct aging-associated abnormalities in cellular messaging, promoting healthy aging in the process.